Sodium Pump, Sex Hormones, and Thrombosis

Project Summary/Abstract
Increased thrombosis risk has been observed in specific conditions, such as heart failure and sex hormone
therapy, yet the underlying mechanisms remain unclear. Platelet activation and aggregation are critical
components of thrombosis, though the function of many platelet proteins remain unexplored.
Sodium/potassium ATPase (NKA), also known as the sodium pump, is a crucial plasma membrane protein
composed of α and β subunits. NKA plays a vital role in maintaining sodium and potassium gradients, cell
volume, and overall cellular homeostasis. Human cells express four α and three β subunits, forming different
NKA isoforms in a tissue- or cell-specific manner. The α1 subunit is ubiquitously expressed, with proteomic
studies suggesting α1β3 as the dominant isoform in platelets. However, the role of NKA in platelet function has
yet to be systematically studied. Using Atp1a1 heterozygous (α1+/−) mice and a 7.5% FeCl3-induced carotid
artery injury thrombosis model, we found that α1 haplodeficiency significantly inhibited thrombosis in male
mice, but not in females, and reduced ADP-induced platelet aggregation in vitro. Alpha1 haplodeficiency did
not alter the NKA’s pump function in platelets. Treating mice with low doses of ouabain or marinobufagenin,
both potent NKA inhibitors, also markedly inhibited thrombosis in vivo. Additionally, ouabain dose-dependently
inhibited ADP-induced platelet aggregation in certain individuals. Immunoprecipitation-immunoblotting assays
revealed that α1 binds to P2Y12, which contains a leucine-glycine-leucine (LGL) motif that mediates the
interaction of some platelet G protein-coupled receptors (GPCRs). Mutation of the LGL motif to serine-
phenylalanine-threonine (SFT) significantly reduced the P2Y12-NKA α1 interaction. In WT mice, females
exhibited elevated platelet α1 levels compared to males, and α1+/− mice had higher testosterone levels than
their WT littermates. While gonadectomy did not affect thrombosis in female α1+/− or WT mice, it significantly
enhanced thrombosis in male α1+/− mice, suggesting an interplay between NKA α1 and sex hormones in
thrombosis regulation. In this project, we will test the hypothesis that α1 modulates platelet activation by fine-
tuning the function of LGL-containing GPCRs, contributing to the elevated thrombosis incidence in heart failure
patients and those undergoing sex hormone treatments or gonadectomy. Aim 1 will clarify how the platelet
NKA α1 subunit regulates the function of LGL-containing GPCRs. Aim 2 will assess whether the NKA α1
subunit is a determining factor in the heightened thrombosis risk linked to sex hormones. This research aims to
provide novel mechanistic insights into the role of NKA, cardiotonic steroids, and sex hormones in platelet
biology and thrombosis, ultimately supporting the development of innovative, safer therapeutic strategies.

Public health relevance
Project Narrative Platelets play a pivotal role in the pathology of thrombosis, yet the increased risk of thrombosis in certain disease conditions remains poorly understood. The primary objective of this application is to uncover the mechanistic role of the sodium pump alpha 1 subunit in platelet function and thrombosis. This research endeavors to offer a novel perspective on thrombosis associated with sex hormones and the usage of digitalis drugs.